Investigation of molecular changes in mGluR5 and SV2A to study synaptic alterations in Alzheimer's disease using PET.

PROJECT SUMMARY/ABSTRACT
This proposal seeks to expand the understanding of Alzheimer’s disease (AD) pathophysiology with the
ultimate goals of enhancing care by ensuring timely/accurate diagnosis, as well as preventing and effectively
treating AD. AD afflicts over 5 million people in the US and no current therapy modifies the course of AD.
Positron Emission Tomography (PET) imaging has been successfully employed to investigate changes in living
humans at the molecular level, aiding in the diagnosis and understanding of AD. Therefore, the neurobiology of
AD can be studied in vivo with multi-tracer neuroimaging and neuropsychological characterization.
Molecular changes at the synaptic level are associated with AD. Metabotropic glutamate receptor
subtype 5 (mGluR5) is present at synapses throughout the cortex and is a mediator of amyloid β induced AD
pathology. Therefore, mGluR5 is a candidate biomarker for AD and a target for therapeutic intervention,
making its detection in AD an important goal. Furthermore, synaptic vesicle glycoprotein 2A (SV2A) is a pre-
synaptic protein with potential as the first in vivo marker of synaptic density. Since synaptic loss is observed in
the earliest stages of AD, SV2A binding stands to be a robust marker of disease progression.
The long-term objective of this proposal is to apply PET methods to understand the neurobiological
changes associated with AD using [18F]FPEB, a specific ligand for mGluR5, and [11C]UCB-J, a specific ligand for
SV2A (synaptic density). This is likely to have a significant impact by (i) determining the changes in mGluR5
receptor availability that occur during AD (Aim 1), (ii) determining the changes in synaptic density that are
detectible during AD (Aim 2), and (iii) understanding the relationship between changes in mGluR5 receptor
availability and synaptic density (Aim 3). These investigations will provide valuable understanding of the AD
disease process and lead to the development of both novel treatments and therapeutic biomarkers.
The proposed program will integrate state-of-the-art biomedical imaging facilities at the Yale School of
Medicine with the robust resources of the Yale Alzheimer’s Disease Research Center. The mentorship team
consists of internationally renowned experts in AD diagnostics and therapeutics, human PET imaging, and
biostatistics. The program will provide the candidate with the skills and experience to become an independent
investigator in the fields of AD neurobiology and PET imaging. Specific training goals include: (i) developing
advanced skills in the conduct of human AD and PET research, (ii) developing expertise in computational and
statistical methods for PET tracer kinetic modeling and image analysis, and (iii) developing an independent
program of AD molecular neuroimaging, all in order to ultimately sustain an independently funded research career.
The career development award proposes structured opportunities designed to develop an expertise in innovative
neurobiological research methods and a career as an independent AD and cognitive disorders investigator.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is a common and progressive illness that leads to impaired memory and thinking, impaired ability to function independently, and profound societal costs (loss of productivity, utilization of health care services, and a significant need of support from caregivers). To expand the basic understanding of Alzheimer’s disease pathophysiology, this proposal aims to utilize two novel radioligands and Positron Emission Tomography imaging to characterize synaptic and receptor level changes that occur in disease. A clearer understanding of synapse and receptor level changes will provide valuable insights into the Alzheimer’s disease process that lead to the development of both novel treatments and therapeutic biomarkers.